AI-assisted Imaging and Prediction of Cardiac Arrhythmia Origins using 4D Ultrasound

PROJECT SUMMARY / ABSTRACT
Cardiovascular disease is the major cause of mortality and morbidity worldwide. Despite significant progress in
biomedical imaging, the imaging of heart rhythm disorders remains a major technological and scientific
challenge. Consequently, the origins and mechanisms for the onset and progression of cardiac arrhythmias
remain largely insufficiently understood. Patients suffering from cardiac arrhythmias have high recurrence rates
and often require repeated therapeutic interventions, in part because adequate imaging of the processes
underlying heart rhythm disorders has yet to be developed. The state-of-the-art for the diagnosis of heart rhythm
disorders, such as atrial fibrillation or ventricular tachycardia, is catheter-based electro-anatomic contact
mapping. However, catheter mapping is time-consuming and invasive, involving the insertion of electrodes into
the heart’s chambers, where abnormal electrical activity triggering the heart’s irregular contractions is recorded
on its surface. Because the measurements are superficial, they do not adequately capture the full, three-
dimensional electrophysiological dynamics, which evolve underneath the surface and often have their origin
inside the heart muscle. In this project, the applicant aims to develop a novel and radically different approach for
the in-depth transmural imaging of heart rhythm disorders based on high-resolution 4D (time-resolved 3D)
ultrasound and artificial intelligence (AI). Instead of imaging the heart’s electrical activity, the applicant will image
the heart’s 4D deformation and use AI to predict the electrical phenomena from the deformation with the precision
of high-resolution measurements. To achieve this ground-breaking goal, the applicant will generate an extensive
high-resolution dataset, capturing the 4D electrical and mechanical dynamics of arrhythmic hearts, and train an
AI to learn the complex relationship between the heart’s deformations and the electrophysiological wave
phenomena that cause these deformations. The AI will become highly specialized in recognizing cardiac
deformation mechanics and associating them with the corresponding underlying electrical arrhythmia
morphology. The data will be generated in beyond-state-of-the-art voltage-sensitive ex vivo fluorescence imaging
experiments with intact, isolated hearts, as well as during clinical imaging and in computer simulations. The high-
risk approach, which preliminary data suggests is achievable, will be enabled by the applicant’s unique expertise
in ex vivo imaging, which, combined with recent advancements in AI, could lead to a major breakthrough.
Ultrasound-based imaging providing transmural 4D visualizations of cardiac arrhythmias in real-time would be
transformative in cardiac electrophysiology and provide novel insights into many of the yet unseen processes
underlying heart rhythm disorders. If successful, the entirely non-invasive imaging technique could greatly
advance the diagnosis of heart rhythm disorders and be used to guide therapeutics, such as catheter ablation,
more reliably and effectively.

Public health relevance
PROJECT NARRATIVE Despite significant progress in the field of biomedical imaging, imaging of life-threatening heart rhythm disorders, such as atrial fibrillation or ventricular tachycardia, remains a major technological and scientific challenge. In this project, the applicant aims to develop a novel imaging technique capable of providing transmural 4D (time- resolved 3D) visualizations of cardiac arrhythmias non-invasively, by predicting electrophysiological phenomena at unprecedented resolutions from the heart’s deformations using 4D ultrasound and artificial intelligence (AI). If successful, the new imaging technique could significantly advance the understanding of heart rhythm disorders, greatly advance their diagnosis and be used to guide therapy more effectively.